Multidisciplinary Research Training in Gastroenterology and Hepatology

PROJECT SUMMARY
The successful sequencing of the human genome and the evolution of human health services research in the
post-genomic era have offered unprecedented opportunities to transform patient care in digestive diseases.
Over the past decade, Weill Cornell Medicine (WCM) has made major investments in biomedical research, as
well as research training and infrastructure. This is a new application from WCM that requests support for the
research training of four clinical and non-clinical postdoctoral fellows in a multidisciplinary research training
program (MRTP) in Gastroenterology and Hepatology, with WCM providing funding for an additional training
slot. The objective is to recruit outstanding candidates with solid foundations in basic science and train them to
apply their knowledge and skills towards addressing important clinically unmet needs in the prevention,
diagnosis, and treatment of patients with digestive diseases. MRTP trainees will receive program support for
two years during which they will follow a structured and rigorous postdoctoral training program. The MRTP will
be a joint effort of 28 eminent preceptors from WCM, Memorial Sloan Kettering Cancer Center (MSKCC) and
the Rockefeller University (RU), which constitute a dense network of collaborative researchers, who are
international leaders in fields directly relevant to gastroenterology and hepatology. These preceptors have
been organized into 3 themed units of research training: gastrointestinal malignancies, liver diseases and
regeneration, and mucosal immunology and inflammation. These training units will enable the development of
content-specific educational programming, as well as increase the efficiency administration within the training
program. Oversight will be provided by a Research Training Executive Committee consisting of the Program
Director and 2 Associate Program Directors, who will also serve as leaders of the training units, as well as 2
additional members who will provide specific guidance on clinical/epidemiologic research and on achieving and
maintaining diversity within the training program. We have also assembled an outstanding roster of internal
and external advisory board members with a mandate to evaluate the program and provide specific
recommendations to improve both its quality and efficiency. The MRTP's highly personalized training program
will include 1) individual development plans; 2) rigorous research training; 3) hands-on experience in cutting-
edge methodologies; and 4) an integrated curriculum. Trainees will further benefit from the extensive
institutional resources of WCM, MSKCC and RU. Based upon the growth in interest in our fellowship programs,
we anticipate a substantial pool of highly qualified clinical and non-clinical candidates for the proposed MRTP,
which will maintain a strong diversity focus. Through its rigorous, structured and highly personalized
curriculum, this new training program seeks to train future leaders in digestive disease research who are
prepared to translate their findings towards improving patient care in the United States.

Public health relevance
PROJECT NARRATIVE This Multidisciplinary Research Training Program in Gastroenterology and Hepatology addresses the critical need for more physician-scientists and scientists focused on gastrointestinal and liver diseases. This Program will provide postdoctoral fellows with rigorous, personalized and state-of-the-art research training. The overarching goal is to equip outstanding young researchers with the knowledge and skills required to accelerate the translation of basic science discoveries into new approaches to the diagnosis and management of digestive disorders.